Affective and Cognative Changes in Alcoholism

DESCRIPTION (provided by applicant): This is an application for the renewal of a Senior Scientist Award (SSA) that began under NIAAA sponsorship on 12/01/96. In keeping with the goals of the prior term of the SSA, its renewal would permit the PI to continue to: (a) devote all of her research efforts to alcoholism, (b) gain needed experience with structural and functional neuro- imaging techniques in the study of alcoholism-related brain abnormalities, and provide mentoring to women scientists. In conjunction with R37 AA 07112, we will examine the interactive effects of alcoholism, aging, and gender. Male and female abstinent alcoholics and nonalcoholic controls ranging in age from 18 to 80 years will participate in behavioral, electrophysiological, and neuro-imaging (MRI) components of the study. In the behavioral tasks, we will vary both the emotional content of the materials presented (emotional words and facial expressions), and the type of cognitive ability needed for task performance. That is, we will separately measure memory encoding and retrieval of the emotional stimuli. Here we make use of the fact that when people use deep encoding strategies (or make inferential judgements about stimuli) to remember information, their retrieval levels are better than if they use shallow encoding strategies (or observe physical stimulus attributes). For the deep encoding operations (i.e., to yield high recognition rates), we will require participants to judge whether a word is abstract or concrete (or whether a face is, or is not, honest). For the shallow encoding operation (i.e., to yield lower recognition rates), participants will judge whether a word is in capital or small letters (or if a face is male or female). For intermediate encoding, participants will judge whether a word (or a face) represents a positive, negative, or neutral emotions. The neuro-imaging portion of the project consists of structural MRIs obtained prior to testing, as well as functional MRIs (FMRI) obtained during task performance while viewing or recalling emotional words or faces. From the scans, we will obtain in vivo correlative information on brain structure and function before, during, and after exposure to emotional stimuli. Regions of interest (R01s) include the pre-frontal cortex and medial temporal areas. As an adjunct to mapping the central hemodynamic (FMRI) changes, we will concurrently record electrodermal activity to examine the coupling between the autonomic and central measures during emotional activation. The structural MRI scans will show the locus and extent of brain abnormalities; the FMRI scans will determine which frontal and limbic regions are participating in all aspects of the tasks; and the electrodermal measures will indicate trials on which the arousal system was, or was not engaged.